Function of high-level visual cortex in awake infants.

Project Summary Functional magnetic resonance imagining (fMRI) has revealed two major principles of the functional organization of the ventral temporal cortex (VTC) in human adults. First, some regions of VTC respond selectively to a specific category of stimuli, such as the fusiform face area (FFA) which responds more to faces than to any other stimulus category. The second principle of organization is that different categories of stimuli have systematically distinct patterns of response across the entire VTC. How do these two key aspects of VTC functional organization in adults arise in development? The goal of my research program is to discover if these organizing principles are present in the infant brain (Aims 1 and 2) and design computational models to test different theories of cortical development (Aim 3). The dissertation work in this proposal will provide invaluable data toward the goal of refining theories of cortical development. In addition to innovations that enhance the quality of awake infant fMRI data, Aim 1 provides the first evidence that like adults, infants have face-selective responses in the FFA, scene-selective responses in the parahippocampal place area (PPA), and body-selective responses in the extrastriate body area (EBA). Aim 2 directly follows this up by asking if infants have systematically distinct patterns of response across higher- level visual areas that are similar to those found in the adult brain. The F99 phase of this proposal will provide training to optimize machine learning (ML) techniques that can withstand the unique challenges of infant fMRI data ? specifically unbalanced and missing data. The F99 phase will be conducted at MIT, an intellectual environment with access to leaders in the fields of ML, cognitive neuroscience, and computational neuroscience. Finally, Aim 3 of this proposal is to build computational models designed to test current theories of cortical development. The K00 phase of this proposal will provide training on the design and implementation of artificial neural networks (ANNs) models as well as training on the best methods to test ANN models using infant fMRI data. Research for the K00 phase will provide a new mentorship experience with an established investigator in computational neuroscience and will take place at an institution with a thriving intellectual environment that has access to an MRI scanner and the computational resources necessary to build a variety of ANN models. In summary, the objective of the proposed research is to determine if the principles of functional organization in the adult brain are present in infants. Insights from this proposal will advance and refine theories of cortical development and have the potential to be applicable to other domains such audition and language. Further, by combining my predoctoral training in awake infant fMRI with my proposed postdoctoral training in computational modeling, the proposed research will enable me to become an independent investigator and leader in the field of computational developmental neuroscience.

Public health relevance
Project Narrative The last 20 years of cognitive neuroscience has revealed the functional architecture of the human brain with an exquisite degree of detail yet has left wide-open the question of what guides the precise development, organization, and structure of the human mind. This proposal outlines a plan to unify developmental cognitive neuroscience and computational cognitive neuroscience to uncover the starting state of the human visual system and how it develops. The proposed research stands to not only inform and refine theories of cortical development and inform our understanding of neurodevelopmental differences, but also has the potential to begin to unravel one of the most intriguing questions available to humanity: what are the origins of the human mind?